Modeling autoimmune pathogenesis and beta cell destruction by T1D immune systems

Project Summary
The study of Type 1 diabetes (T1D) pathogenesis has been limited by the insufficiency of animal models and
the heterogeneity of patient populations, who derive genetic risk from HLA and different assortments of about
60 non-HLA genetic variants. Given this complexity, there is a need for improved models of human T1D
pathogenesis involving diverse genetic backgrounds. We have developed humanized (HU) mouse models in
which T1D patient and healthy control (HC) immune systems are generated de novo from hematopoietic stem
cells (HSCs) in Personalized Immune (PI) mice and models introducing transgenic (Tg) autoreactive TCRs into
their HSCs and T cells. We have also developed methods of generating thymic epithelial cell (TEC) progenitors
and β cells from human pluripotent stem cells (hPSCs) that will increase our ability to test the influence of these
key cell populations on T1D risk. We will use these tools to address the hypothesis that HSC-intrinsic and
thymus-intrinsic genetic variants in T1D individuals lead to abnormal thymic selection of β cell antigen-
autoreactive TCRs. We will: Aim 1: Determine the impact of T1D-prone genotypes on selection of
autoreactive T cells in the human thymus. We have demonstrated negative selection of a Tg HLA-DQ8-
restricted insulin B9-23 peptide-specific TCR in HLA-DQ8+ thymi of HU mice. We will assess additional β cell-
autoreactive class I- and class II-restricted TCRs, determine the impact of both HSC and AIRE+ mTEC antigen
expression and compare selection of T1D patient vs HC thymocytes bearing β cell-reactive TCRs; Aim 2:
Determine the impact of T1D-prone genotypes of TECs on thymic selection of β cell-reactive T cells in
humanized mice. We will utilize a novel model in which hPSC-TECs create a “hybrid thymus” on a living scaffold
of fetal pig thymic tissue that supports human T cell development in HU mice. We will use this model with
genetically engineered hPSCs to determine the impact of human TEC expression of TID-associated genetic
variants on selection of autoreactive TCRs; Aim 3: Assess autoimmune interactions between hPSC-derived
β cells and autoreactive T cells in humanized mice. We have developed models for rejection of hPSC-derived
β cells in HU mice and for autoimmune β cell destruction by transducing autoreactive TCRs into their T cells. We
have generated a hPSC cell line that lacks all HLA except HLA-A2, evading rejection in HLA-A2+ immune
systems. These will be used in vivo and in vitro, with and without expression of an HLA Class II molecule, DQ8,
to model autoimmune destruction by TCR Tg T1D patient and HC-derived T cells, assessing the requirement for
Class II HLA and CD4 help for CD8 cell-mediated autoimmune β cell destruction. Our collaborative effort will
generate novel and robust systems to model human T1D, enhancing understanding of its pathogenesis and
providing a platform for testing of immunotherapies.

Public health relevance
Project Narrative Type 1 diabetes is caused by autoimmune T cell attack on insulin-producing beta cells. The complexity of genetic risk factors for the disease, which are each small but very significant in sum, makes it impossible to model human disease with a single inbred mouse line. We have developed a method of generating T1D patient-specific immune systems de novo in immunodeficient mice that, combined with some unique genetic engineering methodologies in stem cells, we will use to model autoimmune disease development at the level of T cell development and propensity to attack beta cells.